SEER-MEDICARE TECHNICAL SUPPORT SERVICES IN SUPPORT OF THE NATIONAL CANCER INSTITUTE (NCI), DIVISION OF CANCER CONTROL AND POPULATION SCIENCES (DCCPS), HEALTHCARE DELIVERY RESEARCH PROGRA

The National Cancer Institute (NCI), Division of Cancer Control and Population Sciences (DCCPS), Healthcare Delivery Research Program (HDRP), Healthcare Assessment Research Branch requires technical support for SEER-Medicare data users.